Mapping dopamine neuron cotransmission by proximity detection

? DESCRIPTION (provided by applicant): Many brain neurons release a mix of transmitters, but it has been challenging to identify their synapses based on transmitter status. The application of proximity ligation assay (PLA) technology in optogenetic mice offers a way to address these issues comprehensively, enabling visualization of all synapses of an identified population of neurons and their transmitter status. PLA is a hybrid immunochemical and in situ hybridization approach in which two selected epitopes, which are within about 20 nm of each other, generate a discrete fluorescence signal. Synaptic vesicles at the active zone are a distinctive functional element of synapses, which are within 20 nm of the plasmalemma when poised for release. With PLA, we have recently visualized dopamine receptor oligomerization in striatal neurons and addressed the developmental trajectory of dopamine receptor colocalization. In this project, we will use PLA to visualize the proximity of synaptic markers in dopamine neurons to determine key measures of dopamine neuron synaptic function. The specific aims are to: <1> Visualize dopamine neuron synaptic release sites specifically, then visualize dopamine neuron release sites based on the transmitter released. This will be done in optogenetic mice conditionally expressing the exogenous membrane, axon-targeted protein ChR2-EYFP in dopamine neurons by detecting proximity of ChR2-EYFP in the plasmalemma to key synaptic vesicle proteins. <2> Correlate PLA measurements of dopamine neuron connectivity in target areas with functional connectivity to determine the functional readout of the PLA measurements. <3> Demonstrate the ability of PLA to identify synaptic release sites in tissue from wild type mice using proximity of native plasmalemma and vesicular membrane proteins. Stereology will be used for systematic image acquisition and mapping. The quantitative information obtained with PLA will enable asking how does synaptic connectivity change, with regional specificity, over development, and in disease models? PLA will further enable addressing questions such as, where in the brain do drugs impact most, over what time, and for how long? Once prototyped in the dopamine neurons, the PLA approaches developed in this project could be extended to the other major modulatory neuron groups. This will lay the groundwork for post-mortem studies in clinical material, and enable asking, questions such as, which synaptic connections are most affected in disease states, do treatments impact connectivity, are treatments inducing compensatory changes or reversing pathological changes?

Public health relevance
PUBLIC HEALTH RELEVANCE: Dopamine neurons, which are involved in addiction and other major psychiatric disorders, release a mix of transmitters, but it has been challenging to identify their synapses based on the transmitter released. Using a proximity ligation strategy, the synapses of dopamine neurons will be visualized based on the transmitter released, and maps produced that should provide an anatomical readout of functional connectivity.